BACE1 regulation and TNFR Type II receptor in Alzheimers disease

DESCRIPTION (provided by applicant): Clinically, Alzheimer's disease (AD) is characterized by dementia of insidious onset; pathologically, it is characterized by the presence of numerous neuritic plaques, neurofibrillary tangles, and a progressive Neurodegeneration. There is exceedingly strong evidence that abnormal assemblies of Aβ are neurotoxic and have a key role in AD. Why Aβ is increased and accumulates or induces Neurodegeneration is unclear. However, the mechanisms of plaque formation and neurodegeneration in AD brains are not clear. We recently described (He et al., 2007) that generation of amyloid 2 (Aβ), the main component of plaques, is inhibited by TNFRI deletion, which reduces BACE1 levels via the NF-:B pathway. However, we demonstrated in vitro (Shen et al., 1997) that, unlike TNFRI, which is the TNF death receptor, TNFRII, protects neurons. To examine the roles of TNFRII in APP processing, we cross-bred AD transgenic APP23 mice, which express mutant APP and form many Aβ plaques, with TNFRII knockout mice, to generate TNFRII knockout (TNFRII-/-) in APP23 mice (APP23/TNFRII-/-). Our preliminary results demonstrated that APP23/TNFRII-/- mice have more Aβ plaques and increased Aβ levels at 12 months of age. Thus, we propose a central hypothesis that modulation of TNF type II receptor activity can alter BACE1, Aβ production and AD neuropathology via NF-:B-dependent and independent intracellular signaling pathways. We will use the double transgenic mouse model, APP23/TNFRII-/-, to examine whether these mice exhibit earlier AD-like pathology. If so, we will study the mechanisms, such as possible TNFRII mediated BACE1 through new signal transduction pathways by NF-kB dependent and non-NF-kB dependent manner, and how these mechanisms ultimately result in neuroprotection. We believe that successful completion of the experiments will lead to novel therapeutic interventions. The goal of this application is to determine how TNFRII is regulated in neurons and in mouse brains, how it affects the generation of Aβ and its precursors, and whether increased production of TNFRII may be protective and ameliorate Neurodegeneration and AD-like disease in mice. We expect to identify modulators of TNFRII expression and proteins that interact with TNFRII. We also expect to establish that TNFRII is a major modifier of AD pathogenesis and that increasing TNFRII levels reduces disease. If successful, our findings may provide new targets for the treatment of AD and neurodegeneration.

Public health relevance
PUBLIC HEALTH RELEVANCE: Neuronal and synaptic losses are the most prominent features in the Alzheimer's disease (AD) brain. AD treatments are presently inadequate, so numerous novel therapy ideas deserve rigorous exploration in the academic and pharmaceutical research communities. Inhibition of tumor necrosis factor and its mediated signal transduction pathway is one potential target area, like TNF type II receptor (TNFRII) for AD treatment. We recently have started a promising clinical trial with a drug inhibiting TNF signal pathway on AD patients, which is FDA approved and NIH awarded. Thus, elucidating the regulatory mechanisms for BACE1 could identify new potential therapeutic targets and therefore diminish possible side effects that could arise by directly targeting BACE1. Neuronal and synaptic losses are the most prominent features in the Alzheimer's disease (AD) brain. AD treatments are presently inadequate, so numerous novel therapy ideas deserve rigorous exploration in the academic and pharmaceutical research communities. Inhibition of tumor necrosis factor and its mediated signal transduction pathway is one potential target area, like TNF type II receptor (TNFRII) for AD treatment. We recently have started a promising clinical trial with a drug inhibiting TNF signal pathway on AD patients, which is FDA approved and NIH awarded. Thus, elucidating the regulatory mechanisms for BACE1 could identify new potential therapeutic targets and therefore diminish possible side effects that could arise by directly targeting BACE1. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Clinically, Alzheimer's disease (AD) is characterized by dementia of insidious onset; pathologically, it is characterized by the presence of numerous senile plaques, neurofibrillary tangles, and progressive neurodegeneration1-3. The plaques are primarily composed of β-amyloid (Aβ) peptide fragments that are formed when amyloid precursor protein (APP) is cleaved by β- and γ-secretases. Along with others, we found higher levels of BACE1 activity and protein expression in brains with sporadic AD4-6. However, the mechanisms of 'upstream' genotypic events that lead to increased BACE1 levels remain unclear. AD treatments are presently inadequate, so numerous novel therapy ideas deserve rigorous exploration in the academic and pharmaceutical research communities. Inhibition of tumor necrosis factor and its mediated signal transduction pathway is one potential target area. We have recently reported that the deletion of TNFRI inhibits Aβ generation by decreasing β-secretase (BACE1) levels via the NF-κB intracellular pathway7. However, our in vitro study demonstrated that, unlike TNF death receptor (TNFRI), TNF type II receptor (TNFRII) seems to protect neurons8. To examine the role of TNFRII in APP processing, we have cross-bred transgenic APP23 mice, which express mutant APP and show increased Aβ plaque formation9, with TNFRII knockout (KO) mice to generate the TNFRII KO in APP23 mice (APP23/TNFRII-/-). Our preliminary results demonstrated that APP23/TNFRII-/- mice exhibit more Aβ plaques and increased Aβ levels at 12 months of age compared to APP23 mice. Therefore, we formulated a central hypothesis that modulation of TNF type II receptor activity can alter BACE1, Aβ production and AD neuropathology via suppression of NF-κB-dependent and independent intracellular signaling pathways and could lead to novel therapeutic targets. Importantly, the PI recently has started a promising clinical trial with a drug inhibiting TNF signal pathway on AD patients, which is FDA approved and NIH awarded. Thus, elucidating the regulatory mechanisms for BACE1 could identify new potential therapeutic targets and therefore diminish possible side effects that could arise by directly targeting BACE1. Aim 1: Characterize AD pathology of TNFRII in APP mice by targeted deletion of TNFRII alleles. Hypothesis: Genetic deletion of TNFRII in APP transgenic mice results in increased Aβ production and early formation of Aβ plaques. To test this hypothesis, TNFRII-/- mice will be cross-bred with APP23, a transgenic mouse model for AD, and with Tg2576 mice for further confirmation. This will allow us to investigate the role of TNFRII in the modulation of AD-related pathology in the brain. Specifically, we will examine how early Aβ plaques appear and at what levels in the APP23/TNFRII-/- mice. To study whether TNFRII deletion affects Aβ generation, we will examine several aspects of Aβ in the double transgenic mice, including whether Aβ production is increased and whether the product is oligomeric or aggregated. Aim 2: Determine novel roles of TNFRII in the regulation of BACE1 expression and enzymatic activity in vitro and in vivo. Hypothesis: TNFRII negatively regulates BACE1 expression and activity, therefore TNFRII deficiency causes elevated BACE1. Our preliminary results show that the increased TNFRII reduces BACE1 activity and expression levels in vitro. We will test whether elevation of TNFRII expression decreases BACE1 activity in vivo and also examine whether knockout of TNFRII in two different types of APP mice (APP23 and Tg2576) increases expression levels of BACE1 mRNA and protein, as well as BACE1 activity. Aim 3: Identify novel TNFRII-mediated NF-κB-dependent and NF-κB-independent signal transduction pathways that decrease BACE1 expression and activity. Hypothesis: Regulation of BACE1 is mediated by TNFRII and PI3K/Akt and/or by suppression of NF-κB. We will determine whether BACE1 activity is changed by pharmacologically altering ERK (Akt) and TRAF2-induced NF-κB inactivation in various transfected cell lines and in primary neurons isolated from TNFRII-/- double transgenic mice. Aim 4: Examine whether TNFRII regulates neurodegeneration in APP mice. Hypothesis: TNFRII deficiency in APP mice results in neurodegeneration and learning and memory deficits, while TNFRII overexpression can reduce neurodegeneration and improve cognition in TNFRII-/- double transgenic mice. Consistent with our finding that neurons overexpressing TNFRII are highly resistant to Aβ insults in vitro, neurons from TNFRII-/- mice are vulnerable to Aβ toxicity in vitro. In this aim, we will examine whether APP23/TNFRII-/- mice exhibit more neurodegeneration, including synaptic deficits, neuronal function decline, and neuronal loss compared to APP mice with TNFRII. Furthermore, we will restore or increase TNFRII levels in APP23/TNFRII-/- mice by using a lentivirus encoding human TNFRII, which should reverse the pathology and behavioral deficit.